Efficacy Trial of Healthy Juntos: A Family-based Digital Lifestyle Intervention for Hispanic Adolescents and their Parents

PROJECT SUMMARY
Obesity, physical inactivity, and poor diet are major modifiable risk factors for cancer — a leading cause of death
among US Hispanics. US Hispanic youth have the highest rates of pediatric obesity and show faster increases
in body mass index (BMI) from age 12 to <20 years than non-Hispanic Whites. Most Hispanic adults also carry
excess weight, and Hispanic youth and adults do not often meet national guidelines for physical activity and
dietary intake. Family-based interventions can improve health outcomes in both youth and parents and are highly
relevant to Hispanics due to the cultural value of familismo (familism). However, very few existing family-based
obesity prevention interventions for Hispanics target adolescents and their parents, and those that do are not
designed to facilitate widespread reach. An underutilized approach for promoting a healthy weight status among
Hispanics is through digital (i.e., eHealth/mHealth) interventions. US Hispanics are just as likely as non-Hispanic
Whites to own a smartphone and more likely to be smartphone-only internet users. Our team employed a user-
centered approach to develop and pilot a family-based digital lifestyle intervention known as Healthy Juntos
(Healthy Together). This innovative six-month intervention (three-month intensive phase; three-month
maintenance phase), grounded in family systems and behavioral theories, is one of the few obesity prevention
interventions for Hispanic adolescents with digital delivery. It targets improvements in parent BMI and lifestyle
behaviors, family functioning, and health-related positive parenting practices as the means through which
adolescent BMI and lifestyle changes are hypothesized to occur. Unlike existing digital interventions for
adolescents, the intervention makes parents the primary agents of change, with parent-adolescent participation
a team effort through shared decision-making. Given promising findings for Healthy Juntos, the primary goal of
this study is to evaluate, in a randomized controlled trial with 375 Hispanic adolescents and their parents, the
efficacy of Healthy Juntos compared to a digital health referral to publicly available websites and apps (control)
condition in preventing increases in BMI and improving moderate-to-vigorous physical activity (MVPA) and diet
quality among adolescents. The aims of the study are: AIM 1: To determine whether participation in Healthy
Juntos prevents increases in BMI (primary outcome) and improves MVPA, diet quality, and percentage body fat
(%BF; secondary outcomes) in Hispanic adolescents. AIM 2: To examine whether and to what extent changes
in parent BMI and lifestyle behaviors mediate the effects of Healthy Juntos on adolescent outcomes. AIM 3: To
examine whether and to what extent family functioning and health-related positive parenting practices mediate
the effects of Healthy Juntos on adolescent outcomes. We will also explore the role of sociodemographic (e.g.,
acculturation, adolescent sex, weight status, neighborhood deprivation) and user engagement as moderators as
well as the mediating effects of individual-level constructs (e.g., self-efficacy, autonomous motivation).

Public health relevance
PROJECT NARRATIVE This study will evaluate the effects of Healthy Juntos, a family-based digital lifestyle intervention, in preventing increases in body mass index and improving moderate-to-vigorous physical activity, diet quality, and percentage body fat among Hispanic adolescents. It will also examine whether the intervention improves parent weight status and lifestyle behaviors, family functioning and health-related positive parenting practices. The knowledge expected to be gained from this study has the potential to transform the type of obesity and cancer prevention programs that are disseminated to improve the health of US Hispanic families.